Neutral sphingomyelinase in the mechanical regulation of the heart

ABSTRACT
Degenerative cardiac remodeling from chronic overload is a significant contributor to cardiovascular disease.
Signaling pathways initiated by pathologically elevated myocardial stretch are linked to multiple stretch-sensitive
mechanisms, however, the signaling events that occur at the cell membrane to sense and transmit mechanical
signals, at both physiological and pathological conditions, are still poorly understood. We identified neutral
sphingomyelinase (nSMase), a membrane hydrolase enzyme involved in sphingolipid metabolism reactions, as
a critical component of cardiac mechanosensing and mechano-chemical signal transduction. Our findings
indicate that nSMase plays an important role in the regulation of normal physiological function of the heart upon
acute changes in cardiac load, including autoregulatory chronotropic and inotropic responses. At the same time,
chronic mechanical stress results in constitutively active nSMase increasing ceramide production and
accumulation in damaged myocardium. It leads to deterioration of sarcolemmal membrane, elevated production
of reactive oxygen species, blunted β-adrenergic response, and increased arrhythmogenesis, as also observed
during chronic heart failure in patients and animal models of chronic cardiac overload. Moreover, mechanical
and environmental stress is known to provoke certain genetically predisposed arrhythmogenic cardiomyopathy
(ACM) to transition from quiescent to disease phenotype, yet no modulation methods or detection methods are
available. These results position nSMase and associated signaling as key pathways for remodeling in heart
failure and represent promising therapeutic options for mitigating the deleterious effects of cardiac pressure
overload. However, there is limited research on nSMase in the heart. In this application, we will address this gap
in knowledge and will determine the role of nSMase in mechanical regulation of cardiac function in both
physiological conditions and during chronic cardiac overload. We hypothesize that acute activation of nSMase
plays an important role in mechanical regulation of the heart, while chronically elevated membrane stretch results
in constitutively increased nSMase activity which suppresses cardiac function, leads to structural remodeling
and promotes cardiac arrhythmias. We further hypothesize that pathological nSMase signaling, including an
increasing ceramide production and accumulation in damaged myocardium, may serve as an early ACM disease
marker to detect preclinical ACM for genetically predisposed persons and identify people for whom early disease-
modifying treatments may be appropriate. The research has high potential because the mechanistic insights
gained from it can serve as a foundation for recognition of potential biomarkers of myocardial damage and
identifying novel therapeutic targets aimed at prevention of cardiac remodeling during chronic overload.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to the NIH’s mission and public health because it aims to determine the role of mechanosensitive membrane enzyme, neutral sphingomyelinase (nSMase), in regulation of normal physiological cardiac function upon acute changes in cardiac load, including autoregulatory chronotropic and inotropic responses, and in pathological remodeling and arrhythmogenesis during chronic overload, one of the most common causes of cardiovascular disease. Our work will also determine the role of nSMase in the acceleration of cardiac remodeling in genetically predisposed myocardium to define mechano-genomics for arrhythmogenic cardiomyopathy patients. The potential impact of this research is high because the mechanistic insights gained from it can serve as a foundation for recognition of potential biomarkers of cardiac remodeling and myocardial damage and for development of innovative therapeutic strategies aimed at prevention of cardiac remodeling during chronic pressure overload.